A Type 2 Hybrid Effectiveness-Implementation Study of Time Limited Trials to Reduce Potentially Non-Beneficial Treatments for Critically Ill Patients with Advanced Medical Illnesses

Project Summary
Overutilization of invasive intensive care unit (ICU) treatments for patients with advanced medical
illnesses may lead to medical care that provides minimal benefit and prolongs suffering. Although the factors
that lead to overuse of potentially non-beneficial treatments are complex, an important contributor is poor
communication between clinicians, patients and surrogate decision makers. Time limited trials (TLT) involve
detailed discussions of patients’ preferences for care and prognosis followed by agreements between clinicians
and patients/surrogate decision-makers to use certain medical therapies for defined periods of time. TLTs
promote regular structured dialogue between providers, patients and families, reassure them that all indicated
interventions have been pursued, and set rational boundaries to treatments based on patients’ goals of care.
In a pilot study our team showed that utilizing TLTs as the default communication approach for critically-ill
patients with advanced medical illnesses improved shared decision-making and reduced utilization of
potentially non-beneficial ICU treatments. However, key gaps in our knowledge include whether the TLT
intervention can be scaled-up pragmatically in real-life healthcare systems and understanding the factors that
affect implementation and effectiveness. We will conduct a pragmatic type 2 hybrid effectiveness-
implementation stepped wedge clinical trial of the TLT intervention in the ICUs of the Los Angeles County
Department of Health Services (LAC DHS) and Southern California Kaiser Permanente (KPSC) hospitals.
LAC DHS is the second largest public healthcare system in the United States, and KPSC is the largest
integrated healthcare system in Southern California. The patient population in these healthcare systems are
racially and culturally diverse, and many have high risk for breakdowns in shared decision-making due to
socioeconomic disadvantages, language discordance, and low health literacy. The TLT intervention strategy
was co-designed with stakeholders in LAC DHS and KPSC. The specific aims are to: (1) examine whether the
TLT intervention reduces ICU length of stay and utilization of invasive treatments, (2) identify characteristics of
the intervention, participants, and healthcare environment that affect implementation using the Consolidated
Framework for Implementation Research (CFIR) and (3) perform a mixed methods evaluation of
implementation outcomes using the RE-AIM framework. The project team has the transdisciplinary expertise,
established partnerships with stakeholders in LAC DHS and KPSC, and institutional support to complete the
aims of this project. By examining the effectiveness and implementation, this study has the potential to
improve the quality of ICU care in two essential healthcare systems in Southern California and guide
implementation of approaches to improve shared decision-making in other healthcare environments.

Public health relevance
Project Narrative Reducing medical care that has little or no benefit (low-value care) is recognized as an important priority in the U.S. healthcare system and especially important for intensive care units (ICUs) where low-value care is common, harmful, and costly. The goal of the proposed study is to implement a strategy, called time limited trials, that improves communication and shared decision making between clinicians, patients and families about invasive ICU treatments that are unlikely to offer benefit and may cause unnecessary suffering. By examining the factors that influence whether this communication strategy works in real-life healthcare systems, our project will provide foundational information for hospitals and healthcare systems that seek to reduce low- value care and improve shared decision making.